Small regulatory RNA functions in the nucleus

PROJECT SUMMARY
Epigenetics is the study of changes in gene expression or phenotypes that are not the result of changes
in DNA sequence. RNA has emerged as an important informational vector directing many epigenetic processes.
Additionally, for most of the last century it was widely believed that (unlike genetic information) epigenetic
information did not pass across generational boundaries. In other words, epigenetic information was erased each
and every generation such that offspring began life with a blank epigenetic slate. It is now known that this is not
always the case. Many examples of the trans-generational transfer of epigenetic information have now been
documented. The inheritance of epigenetic information for more than one generation is termed transgenerational
epigenetic inheritance (TEI). Non-coding RNAs and, in particular, small non-coding RNAs such as piRNAs,
miRNAs, siRNAs, and tRNAs have now been linked to TEI in plants, worms, insects, and mammals. Thus, small
non-coding RNAs are important informational vectors for TEI in many eukaryotes.
In most eukaryotes, dsRNA induces gene silencing (RNAi). We have used RNAi in C. elegans to identify
factors that couple small non-coding RNAs to transcriptional regulation. Recently, these studies led us to
discover a new type of silencing RNA that we term the pUG RNA. Amazingly, progeny of C. elegans subjected
to RNAi inherit the ability to silence RNAi-targeted genes for many (5-10) generations (termed RNAi inheritance).
Thus, RNAi inheritance in C. elegans is a particular robust example of RNA-directed TEI. We are also using
RNAi inheritance in C. elegans as a model system to explore the mechanistic underpinnings of RNA-directed
TEI in animals. We are using genetic screens to identify cellular factors required for promoting and limiting TEI
and biochemical and cell biological approaches to explore how these factors drive TEI. Finally, we are also using
this system to explore why animals have TEI systems in the first place.
The evolutionarily conserved connections between non-coding RNAs and TEI processes in many
different species suggests that the work we are doing in C. elegans may lead to fundamental insights into
mechanisms of TEI, which will be applicable to eukaryotes in general. The mis-regulation of epigenetic pathways
is known to contribute to the etiology of dozens of human diseases, including cancer. Our proposed work will
likely increase our understanding of how RNA reprograms epigenetic states and, therefore, may help us
understand and, possibly, treat these diseases. Additionally, the question of whether or not people can inherit
epigenetic information from their parents is the subject of intense scientific debate. If people can indeed inherit
epigenetic information from their parents then it stands to reason they could inherit the wrong epigenetic
information, which might predispose to disease. Our work exploring mechanisms of RNA-directed TEI may make
it possible to influence TEI pathways in people to mitigate disease.

Public health relevance
PROJECT NARRATIVE Non-coding RNAs are important regulators of gene expression programs as well as major vectors for transgenerational epigenetic inheritance. We are using the animal model organism C. elegans to understand the mechanism(s) by which non-coding RNAs mediate these important biological processes. The work we are doing may make it possible to influence gene expression programs and epigenetic inheritance pathways in ways that mitigate human disease.